A Convergent Bioengineered Platform for Multifunctional Therapeutic Exosomes

A Convergent Bioengineered Platform for Multifunctional Therapeutic Exosomes
Abstract: The overall goal of this MIRA application is to develop a convergent bioengineered platform for
manufacturing and engineering therapeutic exosomes. The platform will allow the loading of drugs into exosomes
with high efficiency, biomanufacturing of exosomes in high throughput, and further engineering exosome-based
drug delivery systems for various diseases with desired functions including targeted delivery, tracking, and
combinational therapies. Exosomes are a subset of extracellular vesicles, with diameters between 50 nm and 150
nm, secreted by most eukaryotic cells. They are very promising drug delivery vehicles due to their small size,
biocompatibility, low immunogenicity, and reduced toxicity in comparison with synthetic nanoscale formulations
such as liposomes, dendrimers, and polymers. Delivery of anticancer drugs contained in exosomes demonstrated
improved pharmacokinetic and pharmacodynamic properties and enhanced anticancer activity in vivo compared
to free drug molecules. Loading of therapeutic nucleic acids into exosomes protects the nucleic acids from
nucleases and increases cellular uptake and the therapeutic effect due to specific molecular mechanisms of
exosome internalization. Exosomes can cross the blood brain barrier and penetrate deep tissues with improved
efficacy compared to that of synthetic nanocarriers. Moreover, they play a key role in cancer metastasis and
regeneration by inducing transcriptomic and phenotypic changes with their RNA and protein cargoes. Therefore,
they can potentially be reengineered for delivery of gene and protein therapeutics. However, there remain
fundamental challenges to the utilization of exosomes in the clinic: i) drug loading efficiency into exosomes is
very limited; ii) the production of exosomes has yet to reach sufficiently high throughput for clinical tests or even
further development; and iii) endowing exosomes with multiple abilities for satisfactory disease targeting,
tracking and combinational therapies is highly demanding. To address these challenges, the PI proposes the
following three projects: 1) Developing a high-efficiency exosome drug loading technology with chiral graphene
nanoparticles; 2) Developing an exosome production bioreactor with stimulating piezoelectric nanofibrous
scaffolds; and 3) Engineering hybrid exosomes as a multifunctional targeted delivery system with targeting
ligands and functional chiral graphene quantum dots for near-infrared imaging-guided photothermal cancer
therapies. The proposed research contains several innovative approaches of exosome production, loading and
engineering that, if successful and integrated, will provide a high-throughput and high-efficiency exosome
manufacturing platform for drug delivery, and expand exosome-based drug delivery to diverse biomedical and
clinic applications by combining the merits of both the native exosomes and synthetic nanoparticles.

Public health relevance
A Convergent Bioengineered Platform for Multifunctional Therapeutic Exosomes Project Narrative: Exosomes are very promising drug delivery vehicles but there remain fundamental challenges to the utilization of exosomes in the clinic, including limited drug loading efficiency, insufficient production of exosomes with multiple abilities for satisfactory disease targeting, tracking and combinational therapies. Our proposed research is set to address these challenges by developing a convergent bioengineered platform for manufacturing and engineering therapeutic exosomes, which will allow the loading of drugs into exosomes with high efficiency, biomanufacturing of exosomes in high throughput, and further engineering exosome-based drug delivery systems for various diseases with desired functions including targeted delivery, tracking, and combinational therapies. The proposed research contains several innovative approaches of exosome production, loading and engineering that, if successful and integrated, will provide a high-throughput and high-efficiency exosome manufacturing platform for drug delivery, and expand exosome-based drug delivery to diverse biomedical and clinic applications by combining the merits of both the native exosomes and synthetic nanoparticles.